Understanding the Integration of Medical Care and Social Services Under New Payment Models

PROJECT SUMMARY Non-­medical or social factors substantially affect individuals’ health outcomes, quality of health care and medical costs. Services addressing social needs are rarely integrated with routine medical care. Despite the impact of non-­medical factors on the medical system, little is known about the best ways to address non-­ medical needs within the medical system. The Affordable Care Act is changing payment models for health care providers that are attempting to shift from paying for each service provided, which encourages high volume of services, to paying for the quality and efficiency of care, which encourages high value of care. Accountable care organizations (ACOs), the central payment reform in the Affordable Care Act, create groups of physicians collectively responsible for costs and quality of care for a population of patients. Current estimates suggest there are over 700 ACOs in the United States, including approximately 400 ACOs with Medicare contracts and 300 with commercial contracts;? additionally, 18 states are pursuing or implementing ACO contracts within their Medicaid programs. Given the significant impact of non-­medical factors on health outcomes and medical costs, health care providers under ACO contracts may address underlying non-­medical factors as a way to control medical costs and improve quality. Previous research has highlighted the benefits of integrated health care services delivery, but the operational and financial considerations of integrated medical, non-­medical and social services are poorly understood. To understand how ACOs integrate social services within the ACO structure, we will conduct interviews with 20 ACOs. We will explore how ACOs initiate, adapt, modify and sustain their approaches to addressing non-­medical needs and integrating social services into medical care. The interviews will help us examine the motivations or constraints that may have influenced ACOs to adopt or change their approaches. This project leverages our team’s considerable experience with qualitative research with ACO executives, as well as deep expertise on ACO models and specifically how ACO models work for disadvantaged patients. This project will provide important insight into how ACOs achieve greater integration of social services with clinical providers. Results will be of interest to policymakers, providers and payers, and will help them implement ACO programs most efficiently.

Public health relevance
PROJECT NARRATIVE Many patients experience non- medical needs that affect their healthcare, but little is known about how to address these non- medical needs within the medical care system. Accountable Care Organizations, a new policy reform initiative, are aimed at improving the quality of care patients receive while reducing the costs and may be more motivated to meet patient needs – both medical and non- medical. This research will help health care organizations understand how to best meet patient needs.